Dual Reader Protein Sequencing

Project Summary
As it stands today, traditional/standard protein characterization methods have insufficient limits-of-detection,
dynamic range, throughput, cost, accuracy, sensitivity, scale, and/or some combination thereof. Because of
these shortcomings, there are no currently available methods capable of meeting the needs within the
proteomics field: single-cell, proteome-wide characterization/sequencing. New technology must be developed to
advance and revolutionize the field of proteomics, similar to how inventive nanopore-based technology
developments have opened and accelerated the fields of genomics and transcriptomics. Nanopore-based
technology is a very powerful method for molecular characterization and because of this, it has the potential to
also shape the future of protein sequencing. It is one of only a few potential approaches that represent a viable
path to direct, high-throughput, high-sensitivity, single-molecule, protein sequencing capable of characterizing
both low- and high-abundance proteins, which is an absolute necessity for achieving the accuracy and dynamic
range required for comprehensive, enabling protein analyses. During this program, Electronic BioSciences, Inc.
(EBS) aims to develop a completely new nanopore-based technology that will enable de novo protein
sequencing. During this Phase I project, we will develop and build a novel protein sequencing system prototype,
fully assess and optimize the associated workflow/methodology for highly controlled and versatile protein/peptide
characterization, and demonstrate initial sequencing for various proteins and peptides. At the conclusion of this
project, we will have successfully shown concept feasibility for practical nanopore-based protein sequencing.

Public health relevance
Project Narrative The technology developed during this program will yield the first-ever method for direct, high-throughput, single-molecule, protein sequencing capable of characterizing both low- and high-abundance proteins. A de novo, high-accuracy proteomics sequencing technology that can accurately distinguish all 20 natural amino acids, free from costly labels and error-prone enzymes/motors, will greatly advance proteomics research and propel the associated diagnostics, prognostics, and therapeutic intervention strategies into the future.